Leveraging Project ECHO for improved cervical cancer screening in Ethiopia: An implementation study of integrated HPV selfsampling in HIV care centers

PROJECT ABSTRACT
Each year, more than 500,000 women are diagnosed with cervical cancer (CxCa), a preventable cancer
caused by human papillomavirus (HPV) that disproportionately burdens low- and middle-income countries
(LMICs). Women living with HIV (WLHIV) are up to six times more likely to develop CxCa, making them an
especially important target population for prevention and control efforts. In Ethiopia, a national CxCa
screening program was established in 2016 and screening guidelines for WLHIV have recently been updated
to shift from visual inspection with acetic acid (VIA) to human papillomavirus (HPV) DNA testing. There is
limited data on the provider or facility adherence to the “screen-triage-and treat” guidelines and algorithm for
HPV testing; Up to 30% of WLHIV screen positive for HPV and the proportions that are appropriately triaged
with VIA and treated if needed are currently unknown. Implementation challenges to CxCa screening, as
reported by health providers, include high variability in practices between screening sites, and insufficient
training and monitoring and evaluation. We seek to explore and address these challenges through an
implementation science study of point-of-care HPV self-sampling integrated with routine HIV care in
antiretroviral therapy (ART) clinics of hospitals, thereby leveraging established HIV care infrastructure for
improved cancer control of WLHIV. A mixed method situational analysis will be conducted to describe the
existing integration of CxCa screening with HIV care in hospitals, identify opportunities for optimization of the
integrated service, and assess facility readiness to improve the cascade of care. Project ECHO, a facilitated
virtual learner community of health professionals, will be used to promote experience sharing between five
hospitals of which two low-performing sites will receive intensive technical assistance to increase the
proportion of screen-positive individuals appropriately triaged and treated. Acceptability, appropriateness, and
feasibility (implementation outcomes) will be assessed as will ECHO (1) participation, (2) satisfaction, (3)
impact on knowledge, (4) impact on confidence, and (5) impact on professional practice. Finally, a costing aim
will evaluate the cost-benefit of Project ECHO and technical support to inform decision-making around the
sustainability of this approach to improved cancer control in people living with HIV. This study is consistent
with goals of the RFA-CA-23-033 FOA “Implementation Science for Cancer Control in People Living with HIV
in Low- and Middle-Income Countries” by identifying and addressing the unique public health needs of the
LMIC population through a situational analysis and by demonstrating potential for broader implementation of
integrated CxCa screening with patient-centered HPV self-sampling for WLHIV in LMICs and other low-
resource settings, considering scale-up and sustainability in terms of triage and treatment coverage,
implementation, and cost. By considering the entire screening cascade, this study will generate important
insights that go beyond screening uptake, to advance CxCa control for WLHIV in LMICs and to move the
needle on the elimination of an almost entirely preventable cancer that unjustly impacts sub-Saharan Africa.

Public health relevance
PROJECT NARRATIVE This implementation science study examines integration of human papillomavirus (HPV) testing using self- sampling with routine HIV care in antiretroviral therapy (ART) clinics of Ethiopian public hospitals, describes opportunities for improved implementation of the integrated cervical cancer screening service, intervenes to enhance the screening, triage, and treatment cascade for women living with HIV (WLHIV) by engaging key implementers and stakeholders in a virtual peer learning community using Project ECHO, and evaluates effects of doing so. After building knowledge, awareness, and expertise of health professionals in five hospitals, technical support will be provided to select hospitals to catalyze implementation momentum. Approximately 30% of WLHIV test positive for HPV in Ethiopia; this study measures how successfully hospitals are able to move screen-positive individuals to triage and treatment and generates implementation information to inform scale-up of an integrated, patient-centered, point-of-care cancer screening model for WLHIV.